Administrative Core

The BREATHE (Bridging Research, Lung Health, and the Environment) Children's Center will translate findings,
based on our own work and work from other centers, regarding environmental exposures that impact children's
respiratory health and interventions to reduce risk. The major responsibility of the Administrative Core is to
ensure that the combined research translation and investigator development activities contained in this
application achieve impact that is accelerated and amplified beyond that of each of the individual
components. This responsibility requires a strong commitment to the “center concept.” As a result, the most
important function of the Administrative Core is to facilitate interaction between the Translation and Development
Cores, support activities, continue to foster engagement of all BREATHE Center members, and coordinate with
key partners that are integral to the Children's Center mission. The Center Director, Dr. Meredith McCormack,
is a physician scientist and a longstanding member of the CCAUE who has led community-engaged research to
characterize health effects of air pollution. She will work with Dr. Thomas Burke, Deputy Director, who brings
experience applying data and evidence to inform environmental health policy implementation at the national
level. They are well-qualified to lead the integration of the Center and bring together a team with complementary
experience to achieve impact on children's environmental respiratory health from the local to national level. The
BREATHE Children's Center Translation Core will develop and implement novel communication tools, including
the Kids BREATHE Lung Health Dashboard, expansion of the Lung Health Ambassador curriculum, and
development of the volunteer Lung Health Corps. The Development Core will support and mentor early career
investigators from diverse backgrounds to conduct children's environmental lung health research. A key aspect
of the BREATHE Children's Center is the pilot program which is part of both the Translation and Development
Cores and will be integrated and overseen by the Administrative Core. The Administrative Core will also
coordinate the meetings, including weekly meetings, monthly forums and the BREATHE Center Summit. These
events are critical to the planned translation and mentoring activities. The overall goals of the Administrative
Core are to ensure completion of the proposed activities and facilitate interaction and information exchange
within and outside the Center, including with the NIH. In addition, the Administrative Core will be responsible for
promoting and tracking the impact of the Center on in achieving short and long term goals.